Development of Novel mRNA Vaccines Against Mycobacterium tuberculosis

Project Summary/Abstract
Tuberculosis remains one of the top ten leading causes of death worldwide (1). Based on the most current
information from WHO 2020 report, in 2019 an estimated 1.4 million people died from TB and approximately
10,000,000 fell ill (2). The COVID-19 pandemic has led to massive decreases in TB case identification and Stop
TB estimates an additional 1.4 million TB deaths will be registered over the next 4 years (3, 4). This, together
with the growing threat of drug-resistant TB and the co-epidemics of TB with HIV and diabetes makes ending
the TB epidemic more crucial than ever before. A vaccine that prevents adolescents and adults from acquiring,
developing, and transmitting TB would be the single most cost-effective tool in ending the TB epidemic (5).
The TuBerculosis Vaccine Initiative (TBVI) and Treatment Action Group (TAG) TB Vaccine Pipelines report
twelve subunit vaccines including recombinant protein/adjuvant and viral vector vaccines spanning from
preclinical through Phase 3 development (6, 7). Of these, nine include Ag85 (Ag85A or B) and six include
ESAT6. The highly limited antigenic and immunological diversity present in the pipeline is a significant gap in
efforts to develop a novel, effective vaccine. The proposed research is intended to bring needed antigenic and
platform diversity to the pre-clinical TB vaccine pipeline using Moderna’s cutting-edge mRNA vaccine
technology and expertise.
Within the R61 phase of this program, we will first optimize mycobacterial antigen sequences for expression in
mammalian cells using Moderna’s proprietary learnings and algorithms. These principles will be applied to the
development of three candidate mRNA vaccines, including 1) an antigen cassette previously shown to induce
protection in animal models when delivered as a protein plus adjuvant, 2) a new antigen cassette
including novel antigens, and 3) the M72 antigen shown to induce protection in humans when delivered as
recombinant protein with the AS01E adjuvant. We will then use data from murine immunogenicity and protection
studies to select the two best candidates for advancement into the R33 phase. Within the R33 phase, we will
use the guinea pig challenge model to downselect to a final lead candidate for further advancement. Once a final
lead candidate is selected, additional studies will be conducted to further characterize the candidate, including
protection in genetically diverse mice and an immunogenicity study in nonhuman primates to optimize the
vaccination regimen for clinical use.
By the end of this program, we will have a novel lead vaccine candidate ready for advancement into IND-
enabling studies and early development as a vaccine to prevent TB disease in adults and adolescents.

Public health relevance
Project Narrative A new tuberculosis (TB) vaccine is urgently needed to bring an end to the deadly TB epidemic, which, only second to COVID-19, kills more people than any other infectious disease in the world. The only effective strategy to meet the United Nations Sustainable Development Goals and the WHO End TB strategy is a TB vaccine to stop transmission (8, 9), which would be the single most cost-effective tool in ending the TB epidemic (5). The cutting-edge mRNA platform, recently proven as an effective vaccine technology against COVID- 19, combined with rationally selected Mtb antigens and IAVI’s strong track record for vaccine development, make this approach well-positioned to deliver a meaningful impact on public health.